Salmonella infection in the murine brain

The purpose of the study is to investigate bacterial meningitis and inflammation in the meninges using a mouse models of infection with Salmonella Typhimurium. C57BL/6 mice are very susceptible to Salmonella Typhimurium due to an inactivating mutation in the natural resistance-associated macrophage protein 1 (NRAMP1). Nramp1 exerts pleiotropic effects on macrophage functions and plays an important role in the control of several intracellular bacterial pathogens. Genetically susceptible Nramp1-/- C57BL/6 mice are being compared to Nramp+/+ reconstituted C57BL/6 mice that develop a controlled sustained infection over several weeks. Following oral or intravenous administration of Salmonella Typhimurium, viable bacteria can be isolated from the brains and CSF of both Nramp1-/- and Nramp1+/+ mice within 3-6 days. Changes observed in the meninges include; leakage of blood vessels, increase in the number and distribution of Iba1+ cells, appearance of intracellular Salmonella and induction of cytokines. By comparing genetically resistant and susceptible mouse strains, as well as Salmonella mutants, we hope to identify key steps in bacterial meningitis.